Immunobiology and Immune Therapy for Merkel Cell Carcinoma

Summary - Overall: Immunobiology and Immune Therapy for Merkel Cell Carcinoma
Our Seattle-based P01 team, with collaborators around the world, has played a leading role in characterizing the
immune response against Merkel cell carcinoma (MCC), an often-lethal, polyomavirus-driven, skin cancer. We led
clinical trials targeting immune pathways including PD-1 blockade that markedly improved the outlook for patients with
this aggressive disease. Although nearly half of patients derive long-term benefit from PD-1 pathway blockade, there
remains an unmet need to develop new approaches for PD-1 refractory patients.
During the current funding period, our P01 team was highly productive, publishing 77 studies that collectively have
been cited 1,858 times. Furthermore, our group’s contributions resulted in at least five changes to the National
Comprehensive Cancer Network guidelines (with six more anticipated within the next 2-3 years) for the care of MCC
patients, including studies supporting the approval of all three FDA-indicated treatments for MCC. This renewal seeks
to improve our understanding of immune evasion mechanisms and identify therapeutically feasible approaches to
reverse resistance to existing immunotherapies. Our team is uniquely positioned to address important immuno-
oncology questions in the field because: 1) we have created unique immune tools to study T and B cell responses to
Merkel cell polyomavirus (MCPyV)-induced MCC, and 2) our specimen and data repository provides access to
clinically annotated biospecimens from hundreds of patients, including specimens from highly relevant clinical trials of
patients who do and do not respond to immunotherapy.
Project 1 will utilize a high-avidity anti-MCPyV T cell receptor with an activating “immune fusion protein” receptor
(CD200R/CD28) to transduce patient cells and generate highly functional, MCPyV-specific T cells capable of
overcoming HLA class I downregulation on MCC tumors. Biomarker studies will be conducted to determine the
mechanisms involved in response or non-response to this cutting-edge approach. Project 2 will reveal mechanisms
associated with response or resistance to PD-1 pathway blockade by studying pre- and post-immunotherapy
biospecimens, including from multiple clinical trials that originated from this P01. These specimens will be used to
identify clinically targetable aspects of the biology of tumor cells, T cells, and innate immune cells (including
macrophages and dendritic cells) that affect the response to PD-1 blockade. Project 3 is poised to provide exciting
insight into a persistent problem in the field of cancer immunology: how B cells interact with CD4 and CD8 T cells to
combat cancer. We leverage expertise in identifying tumor-antigen specific B cells with the fact that MCPyV tumor
antigens are shared among MCC patients. Excitingly, we found that MCPyV-specific B cells with germinal center
features are highly predictive of patient survival. These studies will be enabled by an exciting new mouse model that is
immune competent and the first to generate Merkel cell carcinomas via the MCPyV oncoproteins that drive human
MCC. Leveraging these opportunities and resources, this uniquely qualified team will identify and validate actionable
mechanisms of immune evasion that will improve the management of MCC and immunogenic cancers more broadly.

Public health relevance
Project Narrative - Overall: Immunobiology and Immune Therapy for Merkel Cell Carcinoma This proposed Program Project renewal will leverage our leadership role in establishing Merkel cell carcinoma (MCC) as an ideal model to advance the understanding of immunogenic and pathogen-driven cancers. Having published 77 papers on MCC in the first funding period, we will continue to determine the relevant immune evasion mechanisms at play and what combination therapies would provide the best chance of benefit for PD-1 refractory patients. Utilizing the unique biology of MCPyV-induced MCC and an extensive specimen repository & clinical outcomes database, we are poised to address important challenges in the field: overcoming immune checkpoint therapy resistance through a next-generation approach for transgenic T cell receptor therapy (Project 1); validation of targetable mechanisms of resistance to immune checkpoint therapy (Project 2); and broadening our understanding of how B and T cells interact to target MCC and other cancers (Project 3).